The Development of Tabletop Brain-Mapping Platform

PROJECT SUMMARY
Central Nervous System (CNS) disorders place an enormous burden on society and are among
the most challenging areas for which to develop a therapeutic. A major reason for this is that the
brain is a complex, 3D, multiscale organ, with a heterogenous distribution of components across
hundreds of brain regions. Currently, extensive BRAIN Initiative efforts are underway to map
this complexity by conducting surveys of connectivity pattern and cell types. The new field of
'Spatial Biology' is proving to be a central player in these endeavors.
While contemporary histological methods such as IHC are limited to imaging three or four
proteins, Spatial Biology approaches can investigate tens to thousands of proteins and mRNA
transcripts. Unfortunately, barriers to applying spatial biology techniques in whole 3D brains
are substantial, including the high cost of instrumentation, incompatibility with thick tissues,
and extensive data management, analysis, and visualization challenges. Even older, well-
established tissue protocols are difficult to apply across the whole brain, and serial section
analysis with 2D sections is formidable obstacle due to its labor intensive and error prone
nature. Together, these difficulties present a significant barrier to applying both old and new
histological techniques to the whole brain and thus hinders progress in understanding the CNS.
This proposal will help alleviate this barrier by bringing to market an affordable, table-top
hardware and software mouse brain imaging and tissue processing platform accessible to the
non-specialist neuroscience lab. It is based on a microtomy, section capture, and slide mounting
technology recently released in TVI's state-of-the-art, multiphoton-based TissueCyte platform.
This proposal will extend the capabilities of the TissueCyte platform to sections as thin as 10
microns and replace the TissueCyte's advanced multiphoton imaging with less expensive block-
face imaging. In this Phase II proposal we will package this new integrated tissue processing
technology into a convenient, affordable tabletop instrument. This ground-breaking device will
combine the ease of working from 2D sections with the power of 3D brain analyses and help
propel forward progress in the field of neuroscience.

Public health relevance
PROJECT NARRATIVE This Phase II proposal describes the development of an automated whole-brain mapping platform. It images and sections whole mouse brains into a series of thin sections automatically mounted on glass slides indexed to their correct location within the 3D brain. It offers wide compatibility with advanced Spatial Biology techniques and existing histology methods including classical CNS and neurodegenerative markers and immunohistochemistry protocols. The device has an integrated brain mapping software platform that allows individual research labs to conduct whole brain mapping studies without the need for specialized equipment or personnel.